COMMITMENT, STRESS AND PROFESSIONAL CAREERS

This study represents the next phase in a long-term investigation of how health and human service professionals change over time. Ten years ago I studied socialization and adaptation during the first year of the career. The subjects were from the fields of public health nursing, high school teaching, mental health, and law, and worked in publicly funded institutions. I now propose to study again the original 26 subjects in order to learn how their perspectives as professionals have developed since then. In addition to conducting in-depth interviews with each subject, I also will administer two questionnaires, one to the subjects and the other to two confidants. These questionnaires will be used to corroborate the interview findings and serve as instruments in a future study with a new, larger sample of professionals at a comparable point in the career. The proposed study will address five related questions. First, how have the subjects' careers changed during the last 10 years? Second, have there been changes in their attitudes towards work, clients, and the helping process -- particularly their degree of commitment and caring? Third, why have changes in work situation or attitude occurred? Fourth, does there seem to be any relationship between initial career experience and subsequent career development? Finally, what are the subjects' current career goals and the most significant sources of work stress, and how are these goals and stresses affecting their commitment and caring?